Community Engagement Core

ABSTRACT (Community Engagement Core)
Consistent with the Michigan Center on Lifestage Environmental Exposures and Disease (M-LEEaD) theme,
Community Engagement Core (CEC) activities focus on linking environmental health priorities identified by
community members and decision makers with the expertise of Michigan Center on Lifestage Environmental
Exposures and Disease (M-LEEaD) researchers on environmental exposures over lifestages and their
implications for health. The overarching vision of the CEC is to increasing understanding among researchers of
community environmental health priorities to inform center research, expanding the use of environmental
health science in decision making, and promote scientific understanding of effective strategies to assure
multidirectional communication and effective engagement. We seek to foster multidirectional dialogue among
community members including youth, policy makers and public health decision-makers and Center researchers
to enhance awareness, understanding and the application of scientific knowledge about the role of
environmental exposures in disease through translation of community concerns to center scientists and
translation of findings to community member and decision makers. CEC activities focus on three primary
audiences: organizations and community leaders with capacity to reach residents in Southeast Michigan,
particularly Detroit; youth from communities experiencing disproportionate exposures and impacts,
representing the next generation of environmental health scientists, advocates and decision makers; and
current policy and public health decision makers in at the local, state and regional, levels. We will accomplish
our vision by: 1) enhancing, expanding, and sustaining partnerships with stakeholders; 2) facilitating
communication between communities experiencing excess risk, policy and public health decision makers, and
M-LEEaD researchers; 3) increasing access to environmental public health research among communities
experiencing excess health risk, policy makers and public health decision makers; and 4) advancing the field
of community engagement through evaluation of CEC process and outcomes, dissemination of results locally
and nationally, and promotion of participatory models for national implementation. CEC encompasses rigorous
evaluation methodology to further the science of participatory engagement and research translation. The
proposed vision and activities maintain and strengthen multidirectional dialogue across investigators with
expertise in physical and social environments and health with youth, adults and organizations representing
environmentally exposed communities, and policy and public health decision makers. This dialogue will inform
environmental health research across the lifestage and improve its translation to inform environmental health
interventions and policy decisions.